Introducing a novel computational framework for B-cell epitope prediction based on immune-induced selection signatures

Project Summary
The accurate prediction of B-cell epitopes is essential for disease analysis, diagnostic tests, and
vaccine design, yet it lags behind T-cell epitope prediction in precision. This is due to the
complex nature of B-cell epitopes and the undersampling of mapped antibody-antigen structural
data. To address this, we propose calculating the intensity of immune selection as an indicator
of immunodominance because immune response-driven selection leaves detectable genetic
signatures around common regions targeted by antibodies. Our preliminary data suggests that
surface-adapted immune selection statistics recover common epitope sites in Sars-Cov-2 Spike,
Influenza HA1, and malaria antigens. We have set out two primary aims to enhance B-cell
epitope prediction. Aim 1: we plan to build a novel and comprehensive antigen database from
68 human pathogens, which maps 3D immune selection profiles onto the surfaces of antigens
from common pathogens. Antigens will be selected from IEDB and their underlying population-
level variation will be extracted from public genomic resources. Population genetics scores,
such as Tajima's D and BetaScan, will be calculated on antigen surfaces. The resulting
database will be deployed online for easy public access. Aim 2: we will develop a B-cell epitope
predictor with two innovations. First, the training output comes from the normalized selection
statistics of antigen surface instead of relying on antigen-antibody structures. Second, structural
features for training inputs will be encoded through the Holographic-CNN model. The predictor's
efficacy will then be compared against the state-of-the-art models using a distinct test set of
experimentally resolved antigen-antibody structures. Upon completion, our predictor is expected
to substantially elevate the predictive power of B-cell epitopes. Our antigen selection database
will provide unparalleled new information for various research purposes of antigen evolution.
These tools will be instrumental for reverse vaccinology, especially the design of epitope-based
vaccines and the evaluation of the potential effectiveness of immunological interventions.

Public health relevance
Predicting B-cell epitopes is the first step in designing effective epitope-based vaccines. We propose to train a novel B-cell epitope predictor informed by immune selection as a result of host-parasite coevolution. To achieve that, we will construct a comprehensive database of immune selection profiles of diverse antigens and train the predictor with a holographic representation of structural information as input, which we expect to significantly improve the current state of epitope prediction.